NUTRITION AND CANCER CURRICULUM FOR NURSES

Long-term Objectives: In 1981 it was reported that 35% of cancer mortality in the USA can be attributed to diet (Doll & Peto, '81), but Nutrition education of health-care professionals has remained woefully inadequate. The University of North Carolina is developing an interactive multimedia course (eight modules) on Nutrition in Medicine for medical students. 70 US medical schools have adopted the UNC series; probably all 130 will be using it soon. UNC raised $2 million to produce this software ($450,000 from the National Cancer Institute, the rest from foundations). This budget only allows UNC to produce versions for medical students; Interactive Information Incorporated (i2i) will modify this series to produce versions for practicing health-care providers, their patients, undergraduates, and the public. Specific Aims : During Phase II, the company will modify all eight modules for practicing physicians and nurses, adding: new video, and new art; this modification process will include: formative evaluation during development, efficacy testing of prototypes, and testing of information transfer methods. Technological Innovation : The UNC curriculum on Nutrition in Medicine, is the first of its kind, a comprehensive core course, in interactive multimedia form, designed to teach this increasingly important topic to medical students. All health-care providers need this information; i2i will deliver it.